RESTING ENERGY EXPENDITURE AND BODY COMPOSITION IN HEALTHY 2-6 YEAR OLDS

The goal of this study is to 1) evaluate the use of existing reference standards and establish local reference data for resting energy expenditure, body composition and dietary intake of 2-6 yr. old children;2) establish age appropriate calibration equations for the TOBEC body composition device; 3) determine differences between sleeping and resting energy expenditure; and 4) examine interrelations among these measures in healthy children.